SBIR PHASE II TOPIC 377: ENABLING CLINICAL DECISION SUPPORT FOR GUIDELINE-BASED CANCER SYMPTOM MANAGEMENT (MOONSHOT)

The objective of this proposal is to develop a clinical decision support tool (CDS-Sx) that will leverage national clinical practice guidelines to provide evidence-based guidance to clinicians for the management and surveillance of distressing symptoms in patients with cancer. The tool is designed to collect information directly from patients prior to clinic appointments using validated patient-reported outcome surveys and to provide patient-specific recommendations to clinicians in the context of the electronic medical record. The results of this project will provide a standards-based cancer symptom management tool that will be scalable and sharable across the nation to improve the management of distressing cancer-related symptoms and reduce morbidity, mortality and costs for patients with cancer.